FOCUS: Foreign Born Latinos Cardiovascular Screening

Project Summary/Abstract
Latino immigrants experience numerous disparities in the receipt of routine health care. They are at risk
for significant poor outcomes from cardiovascular disease; however, the extent to which Latino immigrants
experience appropriate cancer screening and prevention services, compared with US born-Latinos and non-
Hispanic whites, is not well understood. This may be, in part, because studying the health care of Latino
immigrants has numerous challenges. Foreign-born status is not widely and routinely collected, and foreign
born patients may not have the access to healthcare related datasets that would objectively record their
healthcare utilization. Additionally, there is some scientific evidence that different sub groups of immigrants
may receive different services; specific ethnic subgroup (Mexican individuals, for instance), Spanish speaking
individuals, rural- residing immigrants may utilize services differently than contrasting groups. However,
knowledge on these differences is incomplete because studies to date have failed to include all necessary data
to understand these relationships.
In order to better understand cardiovascular prevention disparities between foreign-born Latinos, US-
born Latinos, and non-Hispanic Whites, we will leverage a unique data resource from a large, national network
of community health centers with shared electronic health record data that is linked to community-level social
determinants of health data. This large, longitudinal dataset contains country of birth for >87,000 Latinos and
also contains unprecedented data linkages which will let us assess disparities and better understand which
specific groups are most at risk for the under-utilization of cardiovascular prevention. Understanding these
factors that most heavily impact cardiovascular preventive service use is crucial to the prioritization of
population-based interventions to improve cardiovascular outcomes.
This research will enable action/intervention in three ways: 1. It will enable more informed policy
decisions to improve public health and wellness in foreign born Latinos. 2. It will facilitate strategic partnerships
between healthcare providers and community agencies poised to intervene in social factors in the lives of
Latino immigrants. 3. It will help clinical providers understand their patients' barriers to care utilization, and
further point-of-care efforts to address these barriers that influence their Latino immigrant patients' utilization of
recommended cardiovascular prevention services.

Public health relevance
Project Narrative Foreign-born Latinos in the United States are at risk for poor health outcomes, including poor outcomes for cardiovascular disease. It is uncertain whether or not they receive fewer prevention services for cardiovascular conditions, and if so, which specific factors may be most responsible for the lower receipt of these services. This project will use a highly innovative electronic health record database that contains country of birth information and is linked to community information in order provide policy makers and healthcare providers better information about what cardiovascular prevention services their patients or community members are most at risk for underutilizing.